Alt & Reno Core

This proposal outlines a plan to renovate two rooms adjacent to the current biomedical research
laboratory in Arnett Hall, the building on campus at West Liberty University that houses the
Department of Biomedical Sciences. renovate. One room is currently an underused classroom
(approximately 1100 sq. ft.) that will be renovated into a state-of-the-art research laboratory, which
is connected to the current biomedical research lab through a smaller room (approximately 480
sq. ft.) that will be renovated to serve as a shared equipment area. This additional research space
is much needed given the growth we have experienced within our Department of Biomedical
Sciences over the past five years. During this time period, we hired four new biomedical research
faculty (three of which have received funding from WV-INBRE) and started new graduate
programs: MA/MS in Biology and MA in Biomedical Sciences. Furthermore, next year we are
planning to introduce a new biomedical undergraduate research major. As part of this curriculum,
students will be required to complete a minimum of six credits (270 hours) of independent
undergraduate research. We anticipate this unique major will attract more students to West
Liberty University and increase participation in the various biomedical research projects taking
place across campus. However, without improving our current facilities, we will be unable to
manage this expected growth in our research output. Acquiring funds that will allow us to increase
our biomedical research space will allow us to adequately train the future generations of West
Virginia scientists, physicians, and health-care providers.

Public health relevance
The renovations proposed here will create a collaborative biomedical research suite that provides more opportunities for student-driven research and support the development of an undergraduate biomedical research major, a unique major not currently offered at any primarily undergraduate institution in the state of West Virginia.